University of California Launching Future Leaders in Global Health Research Training Program

In response to RFA-TW-21-004, the University of California Global Health Institute (UCGHI), including UC San Francisco (UCSF), UC San Diego (UCSD), UC Los Angeles (UCLA) and UC Davis (UCD), along with a network of 21 collaborating institutions internationally, proposes to continue our successful GloCal Health Fellowship (GloCal). Our international sites are well-established, work in regions with significant health challenges, and stand to benefit from our program’s capacity building, mentorship training and alumni support. GloCal is the only UC-wide health training program, and our track record shows that we: 1) Recruit pre- and postdoctoral trainees from various disciplines and backgrounds who aspire to build interdisciplinary academic research careers in health; 2) Provide outstanding, interdisciplinary education and training in health in collaboration with faculty mentors from participating UC campuses and collaborating international institutions; and 3) Provide each trainee with a rich and enduring mentored research experience that fosters scientific and career development in health. The program also advances long-term objectives to 1) Develop models of interdisciplinary, innovative health research and training designed to ensure healthy lives and promote wellbeing for all; 2) Enhance health networks between the UC and our international partners and recruit faculty leading innovative health research; and 3) Strengthen a long-lasting model of collaboration between the UC and our international partners that develops research capacity that advances locally-led and locally-relevant research. GloCal will recruit candidates from a pipeline of 65 T32 and 13 D43 programs. GloCal trainees are at different career stages, but all receive: 1) A 9 or 12-month, hands-on research experience onsite with one of our international partners—international fellows will spend their first 2 to 3 months of the program at UC and earn a certificate in ‘conducting health research’; 2) A strong, interdisciplinary mentored research experience; 3) Instruction in health through onsite and online courses; and 4) Career development to ensure that they attain their short-term goals and succeed in transitioning to the next career stage. GloCal leadership and standing committees ensure that these program components form a seamless, integrated experience supported by evaluation and continuous improvement. Strengths and innovations of the program include: 1) A unified consortium under UCGHI that includes four UCs at the leading edge of health 2) Recruitment of U.S. trainees from across UC and the UCLA-Charles Drew University partnership; 3) Mentors offering training across various disciplines (e.g., medicine, nursing, dentistry, public health, veterinary science, and social sciences) and in research methods; and 4) Leveraging common resources across the four participating UC campuses (UCGHI, CTSAs and CFARs).

Public health relevance
The fellows and mentors trained by this program will contribute to short- and long-term improvements in global health. In collaboration with 21 low- and middle-income country institutions, fellows’ research will help develop clear and effective programs and policies to advance global public health, including care for HIV, other infectious diseases, noncommunicable diseases, global surgery, cancer, mental health and addiction, sexual and reproductive health, and planetary health.